Emotion processing, gender identity, and differential risk for anxiety and depression in autistic adults

Project Summary/Abstract
Research Project Long-Term Objectives: The project will characterize phenotypic & brain factors related to
co-occurring depression & anxiety in adults with autism spectrum disorder [ASD] without intellectual disability,
with a focus on understudied populations at elevated risk for these conditions: females [ASDf] and gender diverse
[ASDgd] individuals. Results will inform biomarker identification for comorbid depression & anxiety in ASD.
Overall research design: 3 samples of ASD young adults (aged 18-30y) will be examined. All samples share
phenotyping measures; two samples have a common magnetic resonance imaging [MRI] protocol: i) purposively
sampled ASDf, ASDgd & ASD males will undergo phenotyping & MRI; ii) ASDf- & ASDgd-enriched sample will
undergo phenotyping; iii) existing phenotyping & MRI dataset from a study that oversampled ASDf. Aim 1:
Delineate impacts of emotion identification/awareness (alexithymia) & emotion regulation [ER] on depression &
anxiety, and roles of sex & a continuous measure of gender identity in these impacts. Methods: multi-level
modeling of depressive & anxious symptoms collected via ecological momentary assessment [EMA] will examine
alexithymia as a cognitive factor in depression & anxiety, and its association with ER. Aim 2: Delineate brain
networks associated with alexithymia & its impacts on depression/anxiety/ER. Methods: regression modeling will
relate structural & functional MRI brain connectivity metrics to alexithymia, ER & depression & anxiety.
Health Relatedness: ASD adults experience depression & anxiety at elevated rates. Associated with these
conditions, ASD adults show alarmingly elevated levels of suicidality. There is no good understanding of why
this is, and there is relatively little research on mechanisms—including cognitive and neural factors—that
predispose ASD adults to these serious mental health conditions.
Candidate’s Career Goals & Development Plan: Dr. McQuaid’s long-term goal is to become an independent
investigator with a research program focused on ASD in adulthood and factors relevant to improving mental
health in this population. Her short-term goals are to characterize brain & behavioral/cognitive factors that predict
increased vulnerability for depression & anxiety among ASDf & ASDgd adults. Building on her multidisciplinary
background, Dr. McQuaid will receive training in 1) ASD presentations, gender diversity, & phenomenology &
measurement of mood/anxiety in ASD; 2) EMA & computing skills; 3) professional development & open science.
Environment: Dr. McQuaid is supported by a cohesive team of expert scientists with overlapping &
complementary research programs. They will provide an intensive, focused, & seamless mentorship experience,
and their respective expertise & institutional affiliations will provide Dr. McQuaid with the requisite guidance &
resources to achieve the research aims & training goals. Taken together, the research & training, mentor team,
& environment afforded by the K01 will serve as a bridge that will successfully transition Dr. McQuaid from her
current position to that of a fully independent investigator.

Public health relevance
Project Narrative The goal of the proposed research is to illuminate cognitive and neural factors associated with the elevated risk for co-occurring anxiety and depression in young adults (age 18-30 years) with autism spectrum disorder [ASD]. Using structural and functional brain imaging and measures of emotion processing, understudied populations who are at dramatically elevated risk for anxiety and depression will be examined: women and gender diverse adults. Results will advance our understanding of cognitive and brain mechanisms related to elevated risk for anxiety and depression in ASD and inform interventions that will reduce the burden of these serious mental illnesses in autistic individuals.